Web-based Visual and Cognitive Screening Battery for Rural OEF/OIF/OND Veterans

This proposal aims to develop a novel web-based screening battery to test visual and cognitive functioning.
Incorporating five tasks that test contrast sensitivity, visual processing speed, attention, executive functioning,
and memory, the proposed battery will 1) address several important knowledge gaps regarding visual and
cognitive functioning in OEF/OIF/OND Veterans, including covariation in deficits across the visual and
cognitive domains and potential geographical disparities and 2) provide a cost-effective approach to screen
Veterans in rural regions of the United States, improving healthcare services for this under-served population.
The training portion of this proposal will also facilitate the applicant’s long-term career goal of becoming
a full-time fully funded independent investigator at the VA, utilizing basic science research in the fields of vision
science and neuropsychology and translating these findings into novel screening methods that can be
implemented within telemedicine to improve healthcare access for all Veterans, both in rural and urban regions.
The training aims include: 1) training in state of the art visual function and cognitive psychometric assessments,
and services and implementation research 2) training in neuropsychology to understand how visual and
cognitive deficits relate to OEF/OIF/OND Veteran’s mental and physical health issues , 3) Increasing the
candidate’s proficiency in state-of-the-art web-based programming techniques, and 4) allowing the candidate
to progress to an independent investigator status through successfully competing for merit funding through the
VA or other non-VA funding opportunities (i.e., NIH).
DESIGN & METHOD: The first phase of the proposal (Aim 1) involves developing and hosting the screening
battery on the web-based cognitive testing platform TestMyBrain where normative data will be collected from
over 15,000 U.S. volunteers (~50,000 worldwide) along with the WHODAS survey to asses functional disability
across six domains and demographic questions assessing current military or veteran status and access to
healthcare services. In the second phase of the proposal (Aim 2) we will recruit and test 120 OEF/OIF/OND
Veterans from the VA Boston community who will make up three groups: Veterans with visual deficit, Veterans
with cognitive deficits, and a control group of Veterans. These participants will complete the battery four times
over two months, twice in our laboratory and twice in their own homes. Data from the proposed tests and other
neuropsychological measures will be used to assess the reliability and validity of the screening measures.
Finally, geographical disparities analyses between rural and urban participants and Veteran vs. civilian
participants will be completed on this dataset for preliminary needs assessment (Aim 3).
OBJECTIVES: Aim 1: Develop a web-based visual and cognitive testing software program and determine
normative age-based values. Hypothesis 1a: Lifespan trends and age-of-peak performance on our web-based
measures will match published values from corresponding clinical assessments. Hypothesis 1b: Age-adjusted
performance on the visual and cognitive assessments will be correlated with functional outcomes as measured
on the WHODAS questionnaire. Hypothesis 1c: Combining performance measures across the visual and
cognitive domains will predict functional outcomes better than performance measures in either domain alone.
Aim 2: Compare web-based to lab-based testing to assess the reliability and validity of the web-based
measures. Hypothesis 2a: Measurements will have high reliability across time and setting (reliability > 0.7).
Hypothesis 2b: Similar to standard screening tools, measurements will have diagnostic accuracy > 0.6 in
classifying the Veteran group (Control, Visual Deficit, Cognitive Deficit). Aim 3: Characterize regional
differences in performance and relationship to functional outcomes and healthcare access. Hypothesis 3:
Age-adjusted performance measures will show stronger correlations with functional outcomes in civilians and
Veterans living in rural regions. This correlation will be mediated by self-reported access to healthcare.

Public health relevance
Visual and cognitive deficits have a high occurrence in OEF/OIF/OND Veterans. Yet, availability of healthcare resources is not geographically homogenous, and factors such as mobility can limit an individual’s ability to utilize available healthcare resources. Recent developments in web-based testing capabilities and telemedicine applications provide opportunities to address these disparities and develop novel and cost- effective solutions to increase access to healthcare screening. The proposed research will address these issues by developing and employing a web-based visual and cognitive screening battery. We will further obtain normative measurements of visual and cognitive functioning across a nationally representative sample of volunteers, including both Veterans and non-Veterans, and assess the reliability of the screening measures across time and setting. This screening battery has the potential to substantially improve quality of care for under-served OEF/OIF/OND Veterans. .